Summer Undergraduate Research Experiences in Genomic Medicine (SURE-GM)

Summary
New strategies to increase the diversity of biomedical scientists engaged in genetic and
genomic research is a critical goal for continued improvements in human health and genomic
medicine. This goal is especially important in the Deep South, a region in which a large
proportion of the population experiences health care disparities, where there is a large African-
American population, and where many students—from both advantaged and disadvantaged
backgrounds—pursue undergraduate education in the Alabama state university system, or in
historically black colleges or universities (HBCUs) within Alabama.
This R25 application proposes to leverage and build on the collaborative environment at the
University of Alabama, Birmingham (UAB) and the HudsonAlpha Institute for Biotechnology to
develop SURE-GM, a two consecutive summer program tailored for HBCU undergraduate
students that will equip and provide them with the necessary skills, exposures, and experiences
to participate and contribute meaningfully to graduate and/or professional training in genomic
sciences. Twelve scholars per year will be identified and recruited from Alabama HBCUs as
rising juniors. The scholars will spend their first summer at HudsonAlpha engaged in training for
foundational research skills, their second summer at UAB engaged in mentored research, and
will participate in a "One to Two" continuity program during the intervening academic year. A
robust assessment and review process will be developed that allows for real-time feedback and
evaluation. These efforts will lead to greater participation of underrepresented students in the
biomedical workforce, greater diversity of scientists and physician scientists engaged in
biomedical research, and greater appreciation of the roles and potential of genomic medicine in
science and society.

Public health relevance
Narrative Recruitment and retention of underrepresented minority students during undergraduate education is an important goal for improving health care and genomic medicine. This proposal will build on an existing training infrastructure and collaboration between the HudsonAlpha Institute for Biotechnology and the University of Alabama, Birmingham (UAB) to develop a two summer undergraduate research program for students enrolled in Alabama HBCU institutions.